Advancing cross-national research on aging and cognitive function: English/Spanish courses with the Mexican Health and Aging Study and HRS/HCAP global partner studies

This new R25 program, responsive to PAR-22-195, plays a crucial role in the INCLUDE project. Each year, we recruit, train, mentor, and provide career advice to cohorts of 16 post-graduate participants dedicated to mastering Down syndrome (DS) clinical research. Despite the swift growth of INCLUDE, there are still too few laboratories led by URM Down syndrome experts scientists and too few new URM clinical trainees with expertise in Down Syndrome. In full compliance with NOT-OD-25-090 (Notice of Civil Rights Term and Condition of Award), this program is available for all qualified American Citizens and Permanent
Residents. Under the Multiple PI direction of: Ann Cohen, PhD (Pitt); Benjamin Handen, PhD (Pitt); Elizabeth Head, PhD (Irvine); Adam Resnick, MD PhD (CHOP); Jonathan Santoro, MD (USC-Keck) and Gerald Schatten, PhD, Contact PI (Pitt), with Co-I Calvin Simerly, PhD (Pitt), ICRT is overseen by an external Scientific Advisory Board. They, along with the faculty, provide hands-on, face-to-face training in DS
clinical research. Mentoring and career guidance, including balanced life choices, are considered both during the course, with on-going personal career guidance at annual reunions. The Five specific aims are: I. Offer annual ICRT advanced hands-on clinical research lab courses covering DS through the entire lifespan providing conceptual education and clinical research labs and discussions. Candidates apply on-line describing their DS research career trajectories and 16 participants are selected annually. Comprehensive training on fundamentals and methodologies necessary for flourishing careers. Participants implement career planning with senior and junior faculty, peer-to-peer and personalized coaching. II. Provide ongoing Post-Course
Mentoring at Annual Course Reunions, held at INCLUDE-sponsored conferences and monthly ICRT online sessions. Participants are encouraged to articulate their own longer-term Career Trajectories and explore their Career Choices. III. Cultivate and Enhance Intra-INCLUDE Collaborations and Cross-INCLUDE training for all INCLUDE Scientists at courses and reunions. These create a dynamic, robust
and meaningful INCLUDE Community, among colleagues and friends. IV. Demystify the Changing Regulatory Oversight Requirements in Responsible Conduct for Research (RCR) to ensure full compliance with NIH and Institutional guidance, regulations and law. Creating Safe, and Supportive Research
Environments along with a formal Safety Plan are presented. This is so that participants may begin their own research programs in the most effective, timely, and responsible manner. V. Provide Uunbiased, Quantitative Independent Evaluations to track Participants’ Careers, comprehensively and longitudinally, to ensure that ICRT is a wise, effective investment. ICRT will meet and exceed the PAR’s
mandate of training the next generation of DS clinical researchers, 80 additional clinical investigators, and thereby improving the quality of life and health span of those with Down syndrome as well as all Americans.

Public health relevance
This new R25 program, responsive to PAR-22-195, plays a crucial role in the INCLUDE project (Investigation of Co-occurring conditions across the Lifespan to Understand Down syndromE). Each year, we recruit, train, mentor, and provide career advice to a cohort of 16 post-graduate participants dedicated to mastering Down syndrome (DS) clinical research. Despite the swift growth of INCLUDE, there are still too few laboratories led by Down syndrome expert scientists and too few new clinical trainees with expertise in Down Syndrome. In full compliance with NOT-OD-25-090 (Notice of Civil Rights Term and Condition of Award), this program is available for all qualified American Citizens and Permanent Residents. Under the direction of multiple Principal Investigators, Ann Cohen, PhD (Pitt); Benjamin Handen, PhD (Pitt); Elizabeth Head, PhD (Irvine); Adam Resnick, MD, PhD (CHOP); Jonathan Santoro, MD (USC-Keck); and Gerald Schatten, PhD (Contact PI, Pitt), with Co-Investigator Calvin Simerly, PhD (Pitt), the ICRT initiative proposes five specific aims: I. Annual ICRT courses covering DS through the entire lifespan; II. Ongoing Mentoring; III. Fostering Intra-INCLUDE Collaborations and Partnerships; IV. Responsible Conduct for Research training to ensure full compliance with NIH and Institutional guidance, regulations and law; and V. Quantitative Independent Evaluations to track Participants’ Careers, comprehensively and longitudinally, to ensure that ICRT is a wise, effective investment. ICRT will meet and exceed the PAR’s mandate of training the next generation of DS clinical researchers, 80 additional clinical investigators, and thereby improving the quality of life and health span of those with Down syndrome.